GORDON RESEARCH CONFERENCE ON CALCIUM PHOSPHATES--1989

This proposal is submitted to help organize and conduct the 1989 Gordon Research Conferences on Calcium Phosphates, to be held July 24 to 28 at Salve Regina College, Newport, Rhode Island. This meeting is the ninth in a continuous series and allows the interaction of approximately 135 international scientists from universities, industry, and government who study chemistry, biology, physics, dentistry, medicine, biomaterials, mineralogy, oceanography, geology, soil science, environmental science, and related fields and share a common interest in calcium phosphate research. The general theme of the 1989 Conference is "Calcium Phosphate Research - Linking the Basics to Applications," and topics planned for discussion include (1) the nucleation and growth of calcium phosphates; (2) interactions between calcium phosphate minerals and organic matrices in biological systems; (3) remineralization of tooth enamel and root; (4) physicochemical mechanism of dental caries; (5) synthesis, fabrication and properties of new calcium phosphate biomaterials; (6) interactions between calcium phosphate implants and tissue; (7) roles of calcium phosphates in diseases in which mineralized tissues are destructed or pathological calcified deposits are formed; (8) calcium phosphates in industrial and environmental processes; and (9) new experimental techniques in calcium phosphates research. The strength of this Conferences lies in the fact that scientists with highly diverse backgrounds bring their expertise together to exchange scientific information, and generate new approaches for research solutions for problems in all areas of calcium phosphate studies. The meeting thereby contributes to the scientific cooperation and understanding between laboratories both within and outside this country.